EFFECT OF INTRAVENOUSLY ADMINISTERED SCH 52000 ON PARAMETERS OF IMMUNE FUNCTION

The objective of this rising single dose study will be to evaluate the effect of single intravenous injections of SCH52000 on immune cell function, and to determine in a preliminary manner the single dose pharmacokinetics of SCH52000 in healthy male volunteers.